Novel Mechanisms of Cardiac Function and Dysfunction

While the cardiac kinome is comprised of several hundred kinases, the vast majority of the literature is
focused on only a few kinases. Indeed, the function of numerous highly expressed cardiac kinases, many
of which may be potential therapeutic targets, are unexplored. In order to identify novel cardiac kinase(s)
potentially involved in HF development, we employed a combined transcriptome and bioinformatics
approach (Expression2Kinases (X2K)). This integrated approach enabled us to discover the critical role of
serine-threonine kinase Homeodomain-Interacting Protein Kinase 2 (HIPK2) in cardiomyocyte (CM)
biology. Specifically, we employed three different mouse models and AAV9-mediated gene therapy
approaches to define the CM-specific role of HIPK2 and underlying mechanisms. Since there was no
literature connecting HIPK2 to cardiac biology, these studies were entirely novel. HIPK2 has been strongly
implicated in multiple organ fibrosis. However, the role of HIPK2 in fibrotic remodeling of the ischemic
heart is entirely unknown. Herein, we aim to define the role of HIPK2 in adult heart fibroblast (FB) biology
and fibrotic remodeling in the ischemic heart. As a first step towards this goal, we have generated
inducible conditional FB-specific mouse models (FB-HIPK2-KOs driven by periostinMCM and TCF21MCM).
Our preliminary studies suggest that FB-specific deletion of HIPK2 leads to excessive fibrosis and
accelerated cardiac dysfunction post-MI. At the cellular/molecular level, adenovirus-mediated expression
of HIPK2 (Ad-HIPK2) reduced the pro-fibrotic TGF-β1-mediated SMAD-2/3 activation and myofibroblasts
transformation. Therefore, we hypothesize that HIPK2 exerts a critical break on fibrotic remodeling by
inhibiting the canonical TGF-β1-SMAD-3 signaling. The preliminary data strongly support our overall
hypothesis that HIPK2 is a critical negative regulator of FB activation and adverse myocardial fibrotic
remodeling in the diseased heart. Specific aims are designed to critically examine the role of HIPK2 in
cardiac FB biology and fibrotic remodeling of the ischemic heart. The proposed PeriostinMCM and
TCF21MCM models are widely accepted as the strongest tools available for FB-specific in vivo gene
targeting. Furthermore, throughout the proposal, a wide range of in vitro assays have been incorporated
to gain mechanistic insights into the in vivo findings. Thus, the proposed studies are of high significance,
not only by contributing translationally-relevant information to manage ischemic cardiac injury but also by
providing novel mechanistic insights into cardiac pathophysiology.

Public health relevance
Project Narrative This proposal has direct public health relevance since it proposes novel strategies to prevent and treat heart failure which is a major public health problem with a worldwide prevalence of 38 million. By identifying the underlying mechanisms of heart failure, our studies should allow rational development of effective therapeutic approaches to prevent myocardial fibrotic remodeling and heart failure. Thus, the proposed research is relevant to the part of NIH's mission that pertains to developing fundamental knowledge that will help to reduce the burdens of heart diseases worldwide.